Total Synthesis of Bioactive Natural Products

DESCRIPTION (provided by applicant): The goal of this program is to develop new strategies for the synthesis of bioactive molecules in the prenylated indole alkaloid family. The complex natural products that we construct, and their unique derivatives which are only accessible using our strategies, will provide small molecules that will serve as a starting point to identify anticancer compounds that function via novel mechanisms. Our synthetic studies should also lead to insights into the biosynthesis of a subset of the prenylated indole alkaloids for which the biogenesis is not established. Specifically, we intend to develop strategies to synthesize different structural classes of prenylated indole alkaloids including the citrinalins, cyclopiamine, citrinadins and the stephacidins.

Public health relevance
PUBLIC HEALTH RELEVANCE: Finding new and more efficient ways to synthesize complex small molecules derived from natural products is an important pursuit that may lead to improvements in human health, especially the identification of new anticancer compounds. Our goals are to develop new strategies to efficiently construct complex natural products in the prenylated indole alkaloid family and their associated derivatives. These small molecules will positively address the treatment of cancer.